Testing the Efficacy and Mechanisms of an Adapted Resilience Building Intervention in People Aging with HIV

PROJECT SUMMARY/ABSTRACT
Despite evidence that: 1) older people living with HIV (PLHIV) experience a high burden of stress that is
associated with myriad poorer outcomes, 2) psychological resilience may buffer the negative effects of stress
in older PLHIV, and 3) older PLHIV may possess lower levels of this protective factor than seronegative
counterparts, little work has examined strategies to bolster resilience in older PLHIV. In line with the
mission of NIH and PAR-21-069, this R21 proposal, guided by preliminary studies, the Stage Model for
Behavioral Intervention Development, and a strong research team, will advance the science on resilience
interventions by including: 1) AN IMPORTANT UNDERSTUDIED POPULATION: older PLHIV in the Deep
South; 2) A THEORY-DRIVEN RESILIENCE FRAMEWORK: Guided by The Transactional Model of Stress
and Coping, the Protective Factor Model of Resilience, and the Broaden-and-Build Model, we operationalize
resilience as a process whereby individuals with a set of malleable resilience resources for both appraising and
responding to stress are better able to avoid prolonged (or any) disruptions in functioning. We will use a
resilience curriculum that is theoretically grounded in these models and has been optimized with our pilot data;
3) RIGOROUS EXAMINATION OF EFFICACY AND MECHANISMS: We will test intervention efficacy on
resilience resources and momentary stress responses using real-time methods (i.e., experience sampling
method [ESM]). This RCT will randomize 100 older PLHIV aged 50+ to either an intervention condition or an
attention-matched control condition. Our comprehensive battery will include proximal mechanistic measures,
(i.e., ESM measurement of resilience resources and stress reactivity and recovery), and health (i.e.,
psychological functioning and HIV outcomes) measures. Our Primary Aims focus on intervention effects on:
the use of resilience resources and whether such increases drive improved affective stress reactivity and
recovery (Aim 1) and distal health outcomes at three months (Aim 2). Our exploratory aim will examine
moderators of treatment response. Findings will identify intervention mechanisms and inform the
development of potent and scalable interventions for building resilience in older PLHIV and other
diverse populations of older adults.

Public health relevance
PROJECT NARRATIVE Developing strategies to buffer the negative effects of day-today-stress experienced by older people living with HIV (PLHIV) is paramount to promote health and well-being trajectories in this growing and vulnerable population. While the current science outside of the context of HIV suggests psychological resilience is a potentially promising intervention target, little work has examined this intervention target in PLHIV. The proposed R21 will close such scientific gaps by using an ecologically-valid approach to examine the efficacy and mechanisms of an optimized resilience intervention among older PLHIV, which will ultimately provide implications for development of potent and scalable interventions for building resilience in people aging with HIV.